DP21-001 Component A South Dakota PRAMS

PROJECT SUMMARY/ABSTRACT
In 2017 South Dakota ranked #47 in infant mortality, #49 in neonatal mortality, and #31 in
postneonatal mortality despite having one of the lowest rates of low birthweight deliveries
(<2500g; #2 in 2018) and preterm births (<37 weeks; #16 in 2018). A Governor’s Task Force on
Infant Mortality was formed in 2011 with the First Lady serving as the Chairperson. Several
recommendations resulted, including a recommendation to enhance state and county-level data
regarding pregnancy experiences, risk, barriers, outcomes and infant care practices.
Historically, there have been little data available on factors that influence health behaviors and
attitudes of South Dakota mothers around the time of pregnancy. The South Dakota
Department of Health (SDDOH) recognized that the PRAMS survey is a tool to provide that
information and in 2013 contracted with South Dakota State University (SDSU) to provide
Maternal and Child Health (MCH) epidemiological services and to conduct the first statewide SD
PRAMS-like surveys in 2014 and 2016. Since 2017 SDDOH and SDSU have successfully
participated in the CDC-funded PRAMS, consistently obtaining response rates greater than
64%. SD PRAMS data have been disseminated widely in both peer-reviewed literature and in
the form of infographics; it also will be used to address state objectives as part of the upcoming
MCH Title V Block Grant renewal. Domestic violence data are utilized by the Sexual
Violence/Rape Prevention Education group, data on smoking and alcohol use are used by the
Office on Chronic Disease Prevention and Health Promotion, and reports concerning American
Indian mothers are being developed for distribution to individual Tribes and the Great Plains
Tribal Chairmen’s Health Board and Great Plains Tribal Epidemiology Center. The current
proposal is for South Dakota to serve as a Core Surveillance site (Component A) in the CDC
PRAMS. The SD PRAMS will stratify sampling by maternal race (non-Hispanic white, American
Indian, and other races) in order to obtain race specific prevalence rates that can be used to
address racial disparities that occur in South Dakota. The need is significant, the data are being
used, and we have had excellent statewide participation rates.

Public health relevance
PROJECT NARRATIVE South Dakota has one of the highest infant and postneonatal mortality rates in the United States, with large racial disparities. The information obtained from participation in the CDC PRAMS as a Core Surveillance state will provide important information on maternal attitudes and behaviors around the time of pregnancy and help guide maternal and child health programs in the state. Previous participation in the CDC PRAMS has led to significant work and outreach with maternal child health stakeholders.